Gas Marble Therapeutics for the Mitigation of Cutaneous Injury Post-Radiation Exposure

PROJECT SUMMARY
In the event of a radiological emergency, human skin tissues will suffer significant damage by ionization resulting
in disrupted cellular repair processes and delayed wound healing. There has been a growing interest in utilizing
gaseous molecules (H2, CO, NO, Xe) to treat cutaneous radiation injury as they exhibit promising abilities to
regulate oxidative stress, reduce inflammation, provide cellular protection, and limit cellular senescence markers.
However, delivery in the medical gas therapy domain has predominantly centered around inhalation-based
methods requiring gas cylinders, which are impractical for radiological emergency scenarios. As a result, many
gasotransmitters, noble gases, or traditional gases have not yet been tested for their ability to mitigate radiation-
induced injuries. Recently, gas marble technology has emerged as a stable formulation by which to capture and
contain gaseous species. The technology is made possible by the addition of partially wetted micro/nanoparticles
to the air-liquid interface of liquid-entrapped gas. As this fortification strengthens resistance to mechanical stress
and provides remarkable stability it is called a gas marble. These robust preparations could serve as an effective
means of controlled delivery, encapsulating therapeutic gases to function as medical countermeasures against
radiation exposure. The proposed study is for the investigation of medical gases (Xenon) as MCMs to mitigate
and/or treat injury to normal skin cells arising from exposure to ionizing radiation in human tissue in vitro models.
In parallel, computational modeling simulations will identify novel gas-protein targets. Additionally, the gas marble
delivery system will be tested for the first time in a small animal model for its ability to deliver a known
radiomitigating gas (H2) to ameliorate cutaneous radiation injury. Our Aims propose: (1) To investigate by
computational and in vitro skin modeling, xenon gas's ability to bind to molecular targets and function as a specific
drug that can mitigate ionizing radiation-induced biological responses; and (2) To demonstrate the in vivo
feasibility of the gas marble technology for the skin delivery of established radiomitigating H2 gas against
cutaneous radiation injury.

Public health relevance
PROJECT NARRATIVE Therapeutic gaseous species (H2, Xe, CO, NO) exhibit clinical efficacy, yet are largely unexplored as countermeasures against radiation-induced injuries due to lack of a controlled delivery system. To overcome this challenge, we propose a novel delivery system using gas marble technology to entrap and deliver radiomitigating gases. Herein, we aim to identify a new radiomitigating gas (xenon) and gas-protein targets, while also establishing the feasibility of using gas marble technology for transdermal delivery of molecular hydrogen (H2) for the treatment of cutaneous radiation injury in vivo.